Chromosome organization in development and adulthood

Project Summary
The long-term goal of the study is to uncover how human somatic cells regulate proper chromosome
organization during development. While pairing of homologous chromosomes can drive meiotic recombination,
mitotic pairing can lead to detrimental consequences such as allelic mis-regulation and genome instability in
humans. However, it remains largely unknown how mitotic pairing and recombination, is prevented in somatic
cells to avoid genomic instability during continuous cellular division in development.
We have recently revealed that: (a) Dividing human primary cells keep two haploid chromosome sets apart to
either side of the centrosome, or nuclear division axis; (b) A diminished zone, devoid of interchromosomal
linkage components, is present along the centrosome axis, forming the boundary between the two haploid
sets; (c) Simultaneous tracking of individual chromosome oscillation and the spindle axis, demonstrates
ipsilateral restriction of chromosome movement of two chromosome sets from mitosis onset to G1 interphase;
(d) High resolution imaging of a translocation mouse with a supernumerary chromosome reveals that a
maternally derived chromosome is positioned to a haploid set based on parental origin; and (e) This haploid
set-based anti-pairing motif is lost in renal carcinoma cells.
These findings reveal a new model wherein somatic cells impede homologous chromosome pairing by keeping
two haploid chromosome sets apart along a diminished zone of interchromosomal linkage components,
coincident with the centrosome axis. The model predicts that compartmentalization of the individual haploid
sets from each other require biophysical inter-chromosomal linkage properties within a haploid set, along with
an association between the two haploid sets. Anti-pairing of homologous chromosomes is essential for genetic
stability and function in human cells, thus, we predict that the spatial segregation of haploid sets is conserved
among all cell types. Our proposal aims to experimentally test these hypotheses. Successful outcomes of this
comprehensive study will generate new mechanistic information for how anti-pairing of homologs is achieved,
maintained, and regulated throughout the cell cycle. These results would allow us investigate the significance
of higher-order chromosome organization in cellular development that will be critically important for elucidating
new mechanisms of human disease.

Public health relevance
Project Narrative This study aims to uncover how somatic cells regulate proper chromosome organization during human development. Pairing of homologous chromosomes during meiosis accomplishes genetic diversity. However, during mitosis, homologous pairing in somatic cells can lead to genetic instability and tumorigenesis. The proposal explores this significant, yet largely untouched, biological paradigm of how homologous chromosomes achieve anti-pairing organization during cellular development and disease.